Global HIV Implementation Science Research Training Grant

While the scale of the HIV epidemic remains large, it has entered a promising new phase, marked by unprecedented progress and opportunities. In view of the need to rigorously test interventions to improve the uptake, implementation, and translation of recent scientific findings into standard of care (the know-do gap), as well as to evaluate the impact of bringing such interventions to scale, in 2014 we launched a research training program focused on Global HIV Implementation Science. Implementation science is the scientific study of methods to promote integration of research findings and evidence-based interventions into health care policy and practice, thus improving the quality and effectiveness of health services. A key element of translational research, implementation science encompasses a broad range of skills, including epidemiology, biostatistics, sociology, decision science, and health economics.
The long-term objective of the Training Program is to prepare well-qualified individuals for careers as independently-funded researchers and for leadership in global HIV implementation research. We have assembled an outstanding group of faculty from multiple schools, departments, and centers at Columbia University. Our Training Program faculty have distinguished themselves in mentorship and are leading cutting edge implementation science research addressing HIV prevention among populations at increased risk of HIV acquisition; engaging them in the care continuum; TB/HIV service integration; and differentiated service delivery. The Training Program encompasses streamlined coursework based on an individualized training plan; weekly faculty-fellow seminars; tailored mentorship; research experience in a variety of field settings; presentations; manuscript and grant preparation; research seminars and colloquia; and instruction in the responsible conduct of research and methods for enhancing rigor and reproducibility in research. The Training Program also includes rigorous evaluation of the quality and effectiveness of the Training Program, to ensure that trainees achieve the competencies and skills necessary for success as future leaders in HIV implementation science research.
The five-year program aims to support six predoctoral trainees at any given time. Trainees are required to pursue a doctoral degree in Epidemiology and are supported for three years. With stellar faculty, a unique training environment, and unparalleled research opportunities, we are well-poised to continue to lead this novel effort and nurture new investigators trained in multidimensional, interdisciplinary approaches to advance scientific knowledge and demonstrate the impact of interventions.

Public health relevance
PROJECT NARRATIVE Despite recent advances in prevention and treatment, the scale of the HIV epidemic remains large. The Global HIV Implementation Science Research Training Program aims to increase the number of independent investigators with the knowledge and skills needed to rigorously test interventions to improve the uptake, implementation, and translation of recent scientific findings into standard of care (the know-do gap), as well as to evaluate the impact of bringing such interventions to scale. With stellar faculty, a unique training environment, and unparalleled research opportunities in domestic and international field settings, we are well-poised to continue this novel effort and nurture new investigators trained in multidimensional, interdisciplinary approaches to advance scientific knowledge and evaluate the impact of interventions which address this public health challenge.